2024-2028 Annual International Congress on Integrative Medicine and Health (ICIMH)

PROJECT SUMMARY/ ABSTRACT
This R13 five-year application requests support for the 2024-2028 annual scientific conference
entitled, International Congress on Integrative Medicine and Health (ICIMH). The 2024 ICIMH is
to be held in Cleveland, OH from April 11-13, 2024; in Seattle, WA from March 4-6, 2025; in Salt
Lake City,
UT from April 21-23, 2026; in Minneapolis, MN from April 13-15, 2027; and the 2028
ICIMH will be determined closer to the date.
The conference is sponsored by the Academic Consortium for Integrative Medicine and Health
(Academic Consortium), a registered 501(c)(3) non-profit corporation which represents nearly
80 academic health centers and health systems in the U.S., Australia, Brazil, Canada and
Mexico, with programs focusing on education, research
, and clinical delivery of integrative
medicine and models of whole health. This conference will showcase original scientific research
involving integrative health therapies and lifestyle medicine approaches, using keynote and
plenary presentations, oral and poster abstracts, symposia, and workshops. Basic science,
clinical, and health service researchers will present original research and moderate panel
presentations selected through a de-identified peer-review process, using a pool of 80-100
expert reviewers. Leaders in the field are invited to provide keynote addresses and moderate
concurrent research presentations. The Oversight Committee is composed of Co-Chairs, the
Chairs of the Program, Scientific Review, and Fundraising Committees, Chair of the Board of
Directors and Chief Executive Officer of the Academic Consortium. The 18-member Program
Committee, representing diverse leaders from the conventional and complementary medical
research, education
, and clinical communities, has key responsibility for planning the meeting
content, including selecting the plenary speakers and meeting symposia. The 2022 conference
in Phoenix, AZ, had 700 attendees, representing over 62 academic institutions and
organizations from 14 countries; 69% of the 353 scientific abstracts submitted were accepted for
oral or poster presentation. The post-conference evaluation collected reflected 98.9% of
participants rated the conference quality as excellent or good.
This grant is specifically aimed at increasing attendance at the conference of students, trainees,
new investigators, and others with financial barriers to attendance. Most of the funding will be
directed at reducing the student registration rate and providing travel scholarships. Travel
scholarships will be awarded based on submission of an abstract with strong reviewer ratings,
financial need, and bringing diversity to the meeting. Diversity in meeting attendees will be
assessed in part based on training in integrative health fields that are less represented among
established researchers. Overall, the ICIMH has distinguished itself as one of the largest and
highest quality scientific conferences on integrative medicine and health globally via our stated
goal of strengthening research and collaboration in integrative healthcare and whole health
around the world.

Public health relevance
PROJECT NARRATIVE Public scientific conferences where new peer-reviewed work is presented and discussed are crucial to the advancement of all research disciplines. These conferences allow scientists, regulators, funders, and researchers-in-training to come together in a focused setting to explore data from important recent work in their respective disciplines, address issues of common concern, and provide much-needed peer review regarding the emerging knowledge and understanding. The general public benefits enormously and is impacted by way of the improved therapeutic and other scientific advances that make their first appearance at these conferences. NIH’s support of this particular scientific conference has been critical in allowing the extension of benefits of attending to a larger and more diverse audience—in particular, students and fellows in training.